TREATMENT OF HYPERCALCEMIC/HYPERCALCIURIC PTS W/CHLOROQUINE &HYDROXYCHLOR

It is hypothesized that disordered calcium homeostasis in malignant and non-malignant lymphoproliferative disorders may result from the over production of active Vitamin D metabolites in immune cells. The ability of the chloroquine derivatives to inhibit extrarenal 1,25-(OH)2-D production in sarcoidosis, other granuloma-forming states and lymphoma is being assessed. Based upon the four patients entered thus far, it appears that 1,25-(OH)2-D levels drop significantly within days of treatment initiation. An estimated 20 additional patients will be enrolled.